Human Immune System Mouse Core

PROJECT SUMMARY/ABSTRACT
Human Immune System Mouse Core (Core H)
The Human Immune System Mouse Core (HISMC) will provide HU CFAR investigators with humanized mouse
models in which to study human immunodeficiency virus (HIV) infection. In addition, the HISMC will support
early career HU CFAR investigators to access these models through a Voucher program.
Despite extensive correlative studies of HIV-infected persons and ex vivo studies of peripheral blood cells and
tissue biopsies, fundamental questions about HIV pathogenesis and immunity remain unanswered. The ability
to study HIV through controlled perturbations of the immune system is limited in human subjects, and limited
access to human tissue samples makes the investigation of HIV replication and human immune responses to
HIV difficult in compartments other than the blood. Investigators have therefore turned to animal models, but
unfortunately an ideal animal model of HIV infection has remained elusive. Although simian immunodeficiency
virus (SIV) infection of rhesus macaques has provided many critically important insights into retroviral
pathogenesis and immunity, there are differences inherent in macaque immune responses to SIV and human
responses to HIV. Moreover, expenses associated with NHP studies limit access to this model. To address
these limitations, chimeric “humanized mice” with human immune cells have been generated. The HU CFAR
HISMC generates complementary humanized mouse models: human peripheral blood leukocytes (hu-PBL)
mice, hematopoietic stem cells (hu-HSC) mice and bone marrow-liver-thymus (BLT) mice. Studies supported
by the HISMC have demonstrated that these mice recapitulate multiple aspects of HIV infection in humans
such as the presence of an “eclipse phase” of infection following intravaginal challenge; similar depletion of
CD4+ T cell in peripheral blood and mucosal tissues following infection; and support advanced in vivo imaging
of HIV infection by multiphoton-intravital microscopy and bioluminescence imaging. They also offer a model to
study the effect of treatment, such as ART or antibodies, against HIV.
In the coming funding period, the HISMC will provide access to these models of humanized mice as a new
MGH/Partners Healthcare Core. As such, all costs involved in the generation of the mice and their
experimental manipulations are included in the price of the services. The CFAR support will be entirely
directed towards a voucher program to support access of early career HU CFAR investigators to these
services. These vouchers will cover costs related to humanized mice experiments and will be restricted to early
career HU CFAR investigators who have no grant funding for humanized mouse studies from other sources.